SYSTEMIC SCLEROSIS--SOCIODEMOGRAPHIC, BEHAVIORAL, AND IMMUNOGENETIC FACTOR

Systemic Sclerosis (SSc) is a autoimmune disease that affects 1:17,000 persons. Patients with this disease can experience problems with arthritis, muscles, swallowing, the stomach and intestines, the kidney and the heart. The disease can be painful and debilitating and can lead to premature death. There is no cure for Scleroderma and treatment is usually aimed at treating the symptoms. The clinical course and organ involvement in Scleroderma can be variable, so what is a complication in one patient may not occur in another. The objective of the current study is to study environmental, behavioral, cultural, genetic and laboratory factors in a cohert of Scleroderma patients, in order to identify trends, and risk factors for serious complications of the disease. These factors will be studied in Caucasian, Black and Hispanic populations who have been diagnosed less than five years. It will be important to identify patients at high risk for developing serious complications of Scleroderma so that treatment can be modified to impact on their disease.